Ultra-Rapid Optical Platform for Antimicrobial Susceptibility Testing (AST) ofPulmonary Non-Tuberculous Mycobacterial (NTM) Infections

Project Summary:
Nontuberculous Mycobacteria (NTM) encompass over 200 distinct bacterial species naturally
occurring in the environment. Among these, the Mycobacterium avium complex (MAC) stands
out as one of the most prevalent, and it will be a focal point in this project. Our selection of M.
abscessus and MAC as subjects stems from their classification as rapidly growing, multidrug-
resistant NTM species prevalent in soil and water. Notably, the treatment of pulmonary NTM
diseases faces challenges due to elevated rates of antibiotic resistance. Recently, we pioneered
a novel, rapid (< one hour) Antibiotic Susceptibility Testing (AST) technique. This method
leverages the universal rapid stress responses of bacteria, coupled with the sensitivity and
specificity of Surface-Enhanced Raman Spectroscopy (SERS), to deliver unprecedentedly fast
and accurate drug susceptibility determinations.
We aim to optimize the impact of this rapid SERS-AST method by developing components to
parallelize signal acquisitions. This will enable simultaneous acquisition of quantitative drug
susceptibility profiles (Minimum Inhibitory Concentration, MIC) for a range of antibiotics,
facilitating optimal drug selection for treating NTM infections.
Our project will be divided into three main aims. Initially, we will validate the concept of a parallel
Raman reader for SERS-AST with a readout time of less than 5 minutes. Concurrently, we will
design a SERS array card for rapid AST measurements. Finally, we will evaluate our SERS-AST
assay using M. abscessus and MAC as target mycobacteria. Successful completion of these
aims will pave the way for the development of a prototype system in Phase II, which will be
directly comparable to commercial automated AST devices. Our target is to achieve a cost per
test of $10, realized through an assay card format suitable for testing all pathogenic NTMs of
interest.

Public health relevance
Narra�ve: Our project addresses the diﬃcul�es associated with a rapid AST for nontuberculous mycobacteria (NTM). NTM are well know for their ubiquitous presence in the environment and their resistance to many classes of an�bio�cs. This project will complete a proof-of-concept for a novel Surface Enhanced Raman Scatering (SERS) AST that can be completed in less than 1 hour.